Elucidation of the role of Creb5 in promoting the formation and patterning of the intervertebral disc

Project Summary/Abstract.
Spine diseases, including intervertebral disc degeneration, facet joint syndrome, and scoliosis, are common
diseases. Both intervertebral disc degeneration and facet joint syndrome, as well as scoliosis, are frequently
associated with/or may lead to chronic low back pain, which is very common, causing more global disability than
any other condition. The broad, long-term goal of this project is to develop a comprehensive understanding of
both the specification of the cell identity and the regulatory network that regulates the formation and patterning
of the intervertebral disc, which plays a pivotal role in spinal function and is subject to developmental disease,
degenerative disease, and injury. However, like articular cartilage after damage, intervertebral disc cells do not
repair/regenerate well. Thus, it’s critical to identify both the transcription factors and/or the signaling molecules
that determine different cell types (including stem/progenitors) in the intervertebral disc to develop different
strategies to treat spine disease. My recent findings have indicated that the transcription factor Creb5 is
specifically expressed in intervertebral mesenchymal cells before IVD formation; is subsequently expressed in
all the cells in the annulus fibrosus, including both the inner annulus fibrosus (IAF) and the outer annulus
fibrosus (OAF) after IVD formation; and is also expressed in facet joints. Most significantly, I have found that
the morphology of the annulus fibrosus cells is significantly altered in mice engineered to lack Creb5 function;
and that expression of both Prg4/lubricin and the WNT antagonist Wif1 (Wnt inhibitor factor 1) are dramatically
decreased in the intervertebral discs of these mice. Thus, my findings indicate that Creb5 is necessary to maintain
the proper morphology of the intervertebral disc, and is critical to drive expression of both Prg4/lubricin and
Wif1 in the intervertebral disc. Consistent with the importance of Creb5 in the IVD, a genome-wide association
study identified Creb5 as a susceptibility locus for adolescent idiopathic scoliosis in Japan. A more recent
genome-wide association study identified Creb5 as a susceptibility locus associated with surgery for degenerative
rotator cuff disease, which is most often caused by progressive wear and tear of another fibrous connective tissue
(tendon). As Creb5 is specifically expressed in the intervertebral mesenchymal (IM) that gives rise to the
intervertebral disc, in facet joints, and in all the cells of annulus fibrosus, I hypothesize that Creb5 plays a critical
role in the spine and propose to further investigate the role of Creb5 in spine development. This project will
determine the expression pattern of Creb5 during spine development stage and adult stage; will delineate the
fate of Creb5-expressing cells during spine development; and test whether Creb5HA-CreERt2 mice can be an adult
stage genetic tool with temporal control to target all mature annulus fibrosus cells. This project will also identify
both Creb5 regulated genes and chromatin regulatory elements that bind Creb5 in the intervertebral disc.

Public health relevance
Project Narrative The broad, long-term goal of this project is to develop a comprehensive understanding of both the specification of the cell identity and the regulatory network that regulates the formation and patterning of the intervertebral disc, which plays a pivotal role in spinal function and is subject to developmental disease, degenerative disease, and injury. Currently, there is no treatment to stop or reverse the progress of the intervertebral disc degeneration. Successful completion of this proposal will considerably increase our understanding of how cell identity is specified during formation of the intervertebral discs, and will provide the foundation for future studies to regenerate this tissue in degenerative disc disease.